17th Annual Counteract Network Symposium

Summary
The 17th Annual CounterACT Network Research Symposium is designed to provide scientists
working across the chemical countermeasure field with the latest research findings on the mechanisms
of chemical threats, the identification or development of novel countermeasures and their translation to
relevant clinical scenarios. This research conference has been held annually since 2007 and is the main
venue for interactions among the scientists funded by the successful NIH CounterACT Program. The
symposium brings together an emerging set of trainees in this important scientific area and a range of
external investigators with closely aligned interests from federal agencies and potential industrial
partners. There are also a number of guests from other countermeasure programs across the world
and consultants from relevant Federal programs in attendance. The meeting is internationally known
for the high-quality, cutting-edge nature of the science presented and has a track record of progressive
growth over the last 16 years with the strategic funding and oversight from the CounterACT program.
The 17th Annual CounterACT Symposium will be held June 3-5, 2023 in Park City, UT. The program for
the meeting described in this application has been assembled around the themes permeating the NIH
CounterACT Network, which have collectively changed the way we think about the breadth and pace
of discovery and development for countermeasures against existing and emerging chemical threats. In
addition to the Core sessions, where progress in each funded project will be presented, we have also
included Plenary sessions designed to highlight the trajectory of the program as an exemplar of
systematic approaches to understanding the interactions between environmental chemicals and human
mortality or morbidity. To complete the program and to continue to develop a cadre of emerging
investigators in the relevant fields, we have also developed a short Program for trainees designed to:
(1) provide them with the basic background on common mechanisms involved in clinical toxidromes to
maximize their understanding of the science in the broader conference, (2) receive feedback on their
ongoing research projects from experts in the field, and (3) facilitate their interaction with senior
members of the countermeasure scientific community to promote the creation of a new generation of
countermeasure scientists.
We fully anticipate that the scientific discussions, research talks, poster sessions, and other informal
interactions between the participants of this conference will contribute to our understanding of the
mechanisms of major toxic exposures and the fundamental basis for the identification, development
and deployment of relevant countermeasures.

Public health relevance
Narrative Protecting our nation from chemical threats, whether industrial or existential, is the central mission of the NIH CounterACT Network, and this Annual Symposium is the main venue for the presentation of exciting new science and for the exchange of ideas across the network. The Symposium is also designed to allow the incorporation of new ideas from outside the current countermeasure community to help accelerate the program’s ability to address current threats and to lay the groundwork for identifying and interdicting emerging and future threats. Enlarging, and maintaining this particular community, as well as innovating across the field, are vital components of the mission of this 17th Annual CounterACT Network Symposium.